The impact of genetic and environmental factors on meiotic prophase in the human female

PROJECT SUMMARY
Meiotic studies of human fetal ovaries we conducted for over a decade have generated the largest
available human female meiotic database. This unique resource includes matched maternal/fetal
biospecimens for each sample collected from 2008 to 2017, a period of rapid changes in both the
spectrum and levels of endocrine disrupting chemical (EDC) contaminants. The proposed studies
will test the hypothesis that the high meiotic error rate in the human female is driven by both an
innate propensity to error (e.g., due to the protracted nature of female meiosis and differences in
cell cycle control) and environmental factors. We postulate that environmentally-induced effects
will be discernable because they disturb well-defined meiotic relationships. We will expand our
meiotic database for the cohort and characterize the features of a well-known cause of human
aneuploidy, recombination failure. Meiotic profiles for each case in conjunction with exposure
profiles will be used to determine if and how fetal exposure affects the early stages of female
germline development in humans. We also will obtain data on temporal changes in human
exposure to common endocrine disrupting chemical (EDC) contaminants and compare the ability
of different EDCs to transit from the maternal circulation to the developing fetus.

Public health relevance
PROJECT NARRATIVE Chromosomally abnormal pregnancies are the leading cause of miscarriage and birth defects. Most errors leading to chromosomally abnormal conceptions occur during egg development and their incidence is strongly influenced by maternal age. This project will make use of data amassed during ten-plus years of collaborative studies of human fetal ovaries to enhance our understanding of the earliest stages of oogenesis and test the hypothesis that disturbances that predispose to chromosomally abnormal eggs are increased by fetal exposure to manmade endocrine disrupting chemicals (EDCs).